Buy the world a coke and keep it mosquito free

Project Summary
Mosquito-borne illnesses, which are caused by pathogens that are spread through the bites of infected
mosquitoes, are among the most significant infectious diseases worldwide and among the most challenging to
prevent and control. The long-term goal of our research program is to combat mosquitoes through the transfer
of eco-friendly RNAi-based mosquito gene silencing from the bench to the field, resulting in the development of
a new class of eco-friendly pesticides to combat insecticide resistance. The proposed investigation will test the
hypothesis, which is supported by strong preliminary data, that interfering RNA targeting vital mosquito genes,
which has been produced in Saccharomyces cerevisiae, can be effectively delivered to Aedes, Anopheles, and
Culex mosquitoes in soda, resulting in high levels of mosquito mortality. The objective of the proposed study is
to develop the yeast endless soda (YES) feeding station, an innovative soda bottle-based system for
deployment of RNAi yeast insecticides as attractive targeted sugar baits (ATSBs). Preliminary studies suggest
that the yeast-soda combination is more attractive to mosquitoes than existing sugar bait lures, enabling it to
better lure mosquitoes away from feeding on natural sugar sources. Moreover, unlike insecticides that are
presently being deployed in other ATSB systems, the RNAi yeasts to be evaluated in the proposed
investigation are specific to mosquitoes, posing little if any threat to non-target organisms. Soda in plastic
bottles and yeast are inexpensive and readily distributed worldwide, making these reagents excellent
selections for the development of these innovative ATSB bait stations. The project plan includes the following
aims: 1) Generation of an eco-friendly soda and RNAi-based yeast ATSB as a universal mosquito lure that
selectively kills mosquitoes and 2) Development and evaluation of a prototype YES feeding station. The
expected outcome is the development of a consumer accepted ATSB station that can be further evaluated in
field trials and eventually deployed globally to reduce the worldwide mosquito burden.

Public health relevance
Project Narrative The proposed research program aims to develop an innovative new yeast insecticide and soda-based feeder for the control of Aedes (dengue, Zika, chikungunya, and yellow fever virus vectors), Culex (West Nile and lymphatic filariasis vector), and Anopheles (malaria vector) mosquitoes. The intervention is expected to kill mosquitoes yet have little if any impact on non- target organisms.